Administrative Core

The overall goal of the Administrative core is to ensure the effective and efficient operation of Xenbase - a multi-PI resource with two performance sites. The specific aims of the Admin core are to: Aim 1: To provide the administrative and organizational infrastructure necessary to implement our multi-PI plan and to maintain effective operations. Aim 2: To promote coordination and communication between the Development and Curation teams, and to facilitate integration of the different components of the project. Aim 3: To provide mechanisms for oversight and reporting to a) the Xenopus community, b) the External Advisory Board (EAB) and c) the NIH. Aim 4: To facilitate interactions between the Xenbase leadership and the leadership of other Model Organism databases (MODs), Stock Centers, and external resources such as NCBI, UniProtKB and the JGI.

Public health relevance
Narrative The Administrative Core provides the infrastructure and services to implement the multi- PI and multi-site plan. It coordinates communications, integrates the activities of the different components and manages reporting to the NIH and EAB.